T cell expression of inflammatory chemokine receptors

Abstract
In chronic autoimmune conditions, lymphocytes are continuously recruited to the inflamed site to sustain the
pathologic inflammatory response. T cells that migrate to inflamed tissues such as the synovium in rheumatoid
arthritis often express chemokines receptors that detect chemokines produced in response to acute inflammatory
mediators such as TNF or IL-1, including CLL2, CCL3, CCL4, CCL5, and CXCL16. Receptors for these
chemokines, including CCR2, CCR5, and CXCR6, and highly enriched on T cells from joints of RA patients as
compared to T cells in blood or secondary lymphoid organs. Despite the widespread expression of these
receptors on T cells in inflamed sites, little is known about the extrinsic signals or transcription factors that induce
their expression. Expression of CCR2, CCR5, and CXCR6 are not directly linked to a specific T cell effector
subset, such as Th1 or Th17 cells; thus, we hypothesize that a distinct set of factors regulate expression of this
migratory program independent of differentiated T cell effector subsets. Here we will use arrayed CRISPR
screens and cytokine stimulation screens to identify transcription factors and cytokines that promote expression
of CCR2, CCR5, CXCR6 and related chemokine receptors. We will use a combination of epigenetic analyses to
identify common and distinct regulation patterns controlling the genes that encode these receptors. We will use
spatial transcriptomics and human synovial organoids to dissect the interactions within RA synovium that may
sustain expression of these receptors within an inflamed tissue. We expect that this project will reveal dominant
pathways that control coordinated expression of receptors required for T cell migration to inflamed sites and will
nominate new strategies to interfere with pathologic T cell migration therapeutically in ways that are more robust
that targeting individual receptor-ligand interactions.

Public health relevance
Narrative In chronic autoimmune conditions, lymphocytes migrate into inflamed tissues by following specific sets of homing signals released from the tissue. This project aims to discovery signals and molecular regulators that control expression of homing receptors on human T cells, with the goal of modulating these signals to inhibit trafficking T cell trafficking to inflamed sites in autoimmune diseases.